Novel and Rigorous Statistical Learning and Inference for Comparative Effectiveness Research with Complex Data

Project Summary
Comparative effectiveness research (CER) in medicine is commonly conducted to discover and provide infor-
mation on possible differences between alternative drugs or treatments in their effectiveness and safety. Such
information, if reliable and accurate, can help patients, clinicians, and other healthcare stakeholders to make
better-informed healthcare decisions and improve healthcare delivery and outcomes. However, drawing valid
and relevant inferences about treatment effects from observational studies involves effort and expertise from
both subject-matter researchers and statisticians. On one hand, causal inference relies on structural assump-
tions. Two prominent classes of such assumptions are unconfoundedness or instrument variable (IV) assump-
tions. On the other hand, granted the structural assumptions, causal inference also requires statistical modeling
and estimation of population properties and associations from empirical data. The problem of statistical learning
and inference can be challenging, while allowing a large number of candidate regressors such as main effects
and interactions of covariates. The objective of our research is to develop, evaluate, and disseminate a new
set of theoretically rigorous, numerically automated, and practically useful methods of statistical learning and
inference for estimating treatment effects in CER with complex, high-dimensional data. Three specific aims
are (1) high-dimensional inference about population and subpopulation average treatment effects under uncon-
foundedness with multi-valued treatments, (2) high-dimensional inference about local average treatment effects
and IV-dependent average treatment effects on the treated with multi-valued instruments and treatments, and
(3) high-dimensional inference about average treatment effects such as contrasts between survival and hazard
probabilities with longitudinal and survival data. We will investigate applications of the new methods to several
comparative effectiveness and safety studies including a recent study on comparative treatment strategies in
schizophrenia and an ongoing project to evaluate the therapeutic exchangeability of same-class drugs, for ex-
ample, direct oral anticoagulants among patients with atrial fibrillation or atrial flutter or dipeptidyl peptidase-4
inhibitors among patients with type 2 diabetes, while exploiting IVs created by the design of the Medicare pre-
scription drug benefit. We will develop and publicly release user-friendly computer software including transparent
documentation for direct implementation of the new methods.

Public health relevance
Project Narrative The methods and software developed from our research can be widely applied in various medical and epidemi- ological studies to increase the transparency, validity, and accuracy of treatment effect estimation, by reducing the bias and variation associated with ad hoc model building or over-optimistic machine learning. As such, our research will be instrumental in providing patients, clinicians, and other healthcare stakeholders with the infor- mation needed to make better informed healthcare decisions and improve healthcare delivery and outcomes.